YayaGuide: AI-Enabled Personalized Training for Caregivers of Older Adults with ADRD

SUMMARY
CareYaya is developing YayaGuide, a personalized, artificial intelligence (AI)-driven training tool for
caregivers of individuals with Alzheimer's disease and related dementias (AD/ADRD). The growing burden
of AD/ADRD on individuals, families, and the healthcare system is compounded by a shortage of caregivers and
inadequate training opportunities. While existing educational resources and caregiver training programs offer
some support, they often fail to address the unique needs and challenges faced by this population. Barriers to
access, lack of personalization, and low adoption rates limit the effectiveness of traditional training methods.
The YayaGuide prototype app directly addresses this critical need by offering a personalized, AI-powered
training platform designed to empower a new generation of caregivers. By leveraging the technological familiarity
and engagement of Generation Z, YayaGuide fills a crucial gap in caregiver resources. This approach not only
tackles the immediate shortage of skilled caregivers but also fosters early career development in healthcare and
promotes the integration of technology into AD/ADRD caregiving.
This project uniquely integrates scientific insights on multi-modal caregiver education with cutting-edge AI
capabilities. The prototype utilizes a micro-learning curriculum backed by evidence-based best practices in
dementia care, and a conversational agent supports users through training by providing personalized feedback
and suggestions. Machine learning algorithms adapt content to users' demonstrated competencies, while mobile
delivery promotes engagement by fitting into caregivers’ busy routines. Iterative optimization of the interface and
content, with real-world testing and a focus on appealing to all age groups and caregiver skill levels, distinguishes
it from existing platforms. Its advanced approach promises to significantly enhance knowledge retention,
engagement, and adaptability to the evolving demands of caregiving, making it a valuable tool in addressing the
challenges posed by AD/ADRD in an aging population.
For the proposed Phase I project, we will collect quantitative and qualitative data from diverse age groups with
limited caregiving experience to refine our YayaGuide prototype into a beta version suitable for universal
accessibility.
Successful completion of this work will enable a Phase II program focused on integrating additional features,
such as support for multiple languages, educational content on caregiver wellness and health disparities, peer-
to-peer learning capabilities, and built-in notifications to encourage regular app use. Ultimately, YayaGuide aims
to equip caregivers with the knowledge and skills necessary to provide high-quality care confidently.

Public health relevance
NARRATIVE CareYaya is developing an artificial intelligence (AI)-enabled app, YayaGuide, to address the 'lack of personalized training for Alzheimer's and dementia caregivers’. YayaGuide aims to provide a comprehensive solution by offering tailored content, real-time feedback, and accessible features to improve the learning experience for caregivers of all ages and skill levels. By leveraging advanced AI algorithms, YayaGuide ensures that each caregiver receives individualized guidance that adapts to their unique needs and challenges.